Role of MMP3 in cardiac microvascular barrier dysfunction and heart failure during sepsis

Project Summary
Sepsis is a life-threatening multiorgan dysfunction syndrome caused by a dysregulated response to infection,
responsible for over half of hospital deaths and the leading cause of readmissions and hospitalization costs in
the US. Heart failure in critically ill sepsis patients has a mortality rate of up to 70%. Despite 40 years of research,
there is no effective clinical treatment for sepsis-induced cardiac dysfunction (SICD). Vascular hyperpermeability,
a hallmark of sepsis, leads to lung edema and breathing problems, but its role in SICD remains underexplored.
Our recent study suggests that protecting microvascular integrity and reducing cardiac edema (fluid
accumulation in the myocardium) may improve survival in sepsis. Using genetic analysis (gene sequencing), we
found that MMP3 is one of the top regulated genes in septic mouse hearts, with its serum levels significantly
increased in septic animal models, consistent with clinical reports. Our data also indicate that serum MMP3 has
strong diagnostic value for sepsis, surpassing other common biomarkers tested. However, MMP3’s role in sepsis
is not yet fully understood. In our pilot studies, MMP3 knockout (KO) mice showed 1) reduced microvascular
leakage, improved cardiac function, and maintained normal blood pressure, 2) increased survival rates above
90%, and 3) reduced levels of pro-inflammatory cytokines (i.e. iNOS, IL-6)). Moreover, MMP3 is predominantly
expressed in cardiac endothelial cells, and CRISPR/Cas9-mediated MMP3 deletion in endothelial cells further
increased survival following sepsis challenge. Additionally, B1R inhibitor treatment in WT mice reduced MMP3
levels and cardiac microvascular leakage during sepsis. We hypothesize that the endothelial B1R/MMP3
pathway, following sepsis challenge, plays a critical role in inducing cardiac microvascular barrier dysfunction,
leading to the development of sepsis-induced heart failure. Overall, our proposed studies aim to identify the
critical mechanisms behind sepsis-induced microvascular leakage and demonstrate that MMP3 is a novel
therapeutic target for sepsis-induced heart failure. Aim 1 will investigate the role of endothelial MMP3 in
regulating cardiac microvascular permeability and function in sepsis, contributing to the development
of SICD, using an inducible adult EC-specific MMP3 knockout mouse model and EC-MMP3 overexpression via
a novel nanoparticle delivery system developed by Dr. YouYang (Co-I). Aim 2 will define the molecular
mechanism by which B1R regulates MMP3, focusing on several pathways, using advanced molecular
techniques to establish a direct link between B1R and MMP3. Aim 3 will explore the therapeutic effects of
MMP3 inhibition through pharmacological intervention using an MMP3 inhibitor and CRISPR/Cas9-mediated
endothelial-specific gene editing. Together, these studies aim to provide a comprehensive understanding of the
mechanisms underlying septic heart failure and develop novel therapeutic strategies to reduce cardiac edema,
prevent heart failure progression, with the hope of improving the survival of patients with sepsis.

Public health relevance
PROJECT NARRATIVE We propose to investigate the crucial role of MMP3 in mediating cardiac microvascular barrier dysfunction and heart failure during sepsis. Our aim is to identify the B1R-MMP3 pathway as a novel therapeutic target for treating sepsis-induced heart failure, a leading cause of death in sepsis patients. Our findings will establish a new paradigm, providing deeper insights into the mechanisms of sepsis-induced myocardial edema and heart failure, while potentially revealing new therapeutic strategies to improve sepsis treatment and survival.